Biophysical characterization of DNA repair complex TFIIH

TFIIH, which stands for Transcription Factor II H, is a basal transcription factor. But it is also essential for DNA nucleotide-excision repair as well as cell cycle control. TFIIH is composed of 10 subunits and has a molecular weight of 500kDa. So far it can be purified from HeLa cells or limited over-expression in insect cells. With its large size and limited material supply, biophysical and biochemical characterization of TFIIH is limited to low electron microscopy. A number if genetic diseases are due to mutation and inactivation of the components in TFIIH (XPB and XPD). Interestingly XPB and XPD contain helicase motifs, but TFIIH shown no DNA unwinding activity. Structure of XPD from archaeal sources have been determined and various conserved residues are mapped to the structure. But these structures don't show how XPD interact with DNA or how it is associated with other 9 components to form TFIIH. Our collaborator, Dr. Kaoru Sugasawa, and his colleagues have successfully purify small amount of TFIIH from over-expression in insect cells. We have received the expression clones from Dr. Sugasawa in Kobe University and plan to produce all 10 subunits of TFIIH in insect cells. We need to improve the yield and purify enough TFIIH complexes for initial biophysical characterization and hopefully eventual crystallographic studies.

We have obtained cryoEM structures of human TFIIH in complex with lesion DNA and XPC, which is the first lesion recognition protein in the global NER and recruits TFIIH to the lesion site, and XPF, which is the nuclease that nicks the 5 end of the lesion, both structures are at resolution better than 4.0. In addition, we have determined cryoEM structures of lesion handoff from XPC to TFIIH and xPA. The results have been written up and submitted for publication. our efforts in fully understanding NER by reconstituting the lesion excision complex and structural characterization by cryoEM is paying off dividend. Hopefully in the next 12 months we will reach a new milestone.

Since the successes of determining the early steps of GG-NER, we are pursuing the structural and functional elucidation of the later steps in nucleotide excision repair.